Risk and protective factors for common mental disorders among populations during migration. A pilot cohort study among migrants and asylum seekers in Mexico

PROJECT SUMMARY
Forced displacement has reached unprecedented levels and is becoming increasingly protracted with over
75% of the estimated 100 million displaced persons globally expected to live in exile for over five years. Latin
America has experienced the greatest proportional increase in forced displacement across international
borders since 2017. Due to delays in processing asylum applications and policies permitting the widespread
expulsion of migrants and asylum seekers, many migrants and displaced persons are temporarily residing in
northern Mexico near the US border awaiting safety and more durable solutions in another destination.
Displaced populations face significant adversity, human rights violations, and potentially traumatic events that
increase their risk for common mental disorders (CMDs) during their migration journey. The point prevalence of
CMDs is more than three times higher in displaced populations relative to global averages. Despite this
elevated burden, migrants without legal status in the transit or destination country face significant barriers in
accessing basic needs and services, further contributing to distress and the risk of CMDs. Most available data
on mental health among migrants is cross-sectional due to practical and ethical challenges following mobile
populations over time. Longitudinal data are needed to identify modifiable risk and protective factors that could
serve as targets for CMD prevention interventions in this population. Our study team, which represents an
established academic-humanitarian partnership, has expertise conducting mental health research among
displaced populations and providing community-based mental health and psychosocial support to these
communities, including in Mexico. We aim to further this partnership by piloting feasible, effective, and ethical
strategies for recruiting and retaining a prospective cohort of 300 migrants in transit to clarify the factors that
contribute to prevention of CMDs. Using data from this cohort this study aims to: 1) identify risk and protective
factors for CMDs; 2) Estimate the short-term effect of economic services, social protection, legal assistance,
and mental health interventions on reducing the risk of CMDs; and 3) evaluate the feasibility and acceptability
of conducting a fully powered prospective cohort study of migrants in transit in Mexico followed over three
years. This research is the first longitudinal investigation of mental health among migrants in transit, including
underrepresented groups (women, children, separated families), and will innovatively measure the impact of
multisectoral services on mental health outcomes among migrants during this critical phase of migration.
Results from this study will provide critical and novel insights into the epidemiology of CMDs and will enable
the development of targeted and efficient strategies to reduce the incidence of CMDs among migrants in transit
in humanitarian emergencies.

Public health relevance
PROJECT SUMMARY Humanitarian emergencies are leading to unprecedented levels of forced displacement, which increases risk for common mental disorders due to the range of adversities and potentially traumatic events experienced during migration. This study will assemble a prospective cohort of 300 migrants in transit in northern Mexico to clarify the factors and interventions that contribute to prevention of CMDs in this population. As the first longitudinal study of mental health among migrants in transit, this study will provide needed insights into promising targets and approaches for CMD preventive interventions in displaced and mobile populations in complex emergencies.